Pilot trial testing mobile health psychosocial intervention for Adolescentsand Young Adults with cancer

PROJECT SUMMARY/ABSTRACT
In addition to coping with their medical illness, Adolescents and Young Adults (AYAs) with cancer struggle with
the age-related developmental challenges of independence, education, employment, relationships, and
identity. AYAs with cancer are at high risk of poor short-term and long-term outcomes, including poor mental
health, social isolation, risky health behaviors, unemployment, and poor quality of life. With the rapid rise in
digital technologies, skills-based psychosocial interventions are increasingly deployed via mobile health
(mHealth) platforms. Such interventions show promising treatment effects, help overcome barriers to traditional
in-person delivery models, and are highly appealing to AYAs. However, mHealth interventions focused on
improving quality of life and psychosocial outcomes have not yet been successfully evaluated or implemented
among AYA cancer patients. This application builds on my prior work with the "Promoting Resilience in Stress
Management" (PRISM) intervention for AYAs with cancer. This novel, brief, evidence-based 1:1 intervention
teaches stress management, goal-setting, meaning making, cognitive-behavioral, and mindfulness strategies. I
and my team have adapted this in-person intervention to a self-guided mHealth intervention, mPRISM. This
mixed-methods proposal has the following 3 complementary aims: (Aim 1) To evaluate the feasibility,
acceptability, and exploratory efficacy of mPRISM for AYAs with cancer in a pilot randomized trial; (Aim 2) To
analyze backend digital usage patterns in order to identify and target aspects of digital engagement associated
with improvement in psychosocial outcomes; and, (Aim 3) To assess barriers and facilitators to the adoption of
mHealth interventions in clinical settings via semi-structured exit interviews with patient and clinic stakeholders.
This proposal has technological, methodological, and dissemination innovations in potential for scale-up of
interventions to overcome structural barriers to psychosocial treatment access. This K08 will provide
opportunities to acquire skills and knowledge in: advanced clinical trials research as PI; mHealth research
including intervention testing, digital analytics, and strategies to optimize engagement and adoption; and
advanced implementation science methods. The research and career development plan, supported by a multi-
disciplinary team of experts (in AYA oncology, implementation science, mHealth and mobile analytics, clinical
trials research, advanced statistics, and qualitative methods) and in a rich academic environment, will support
the PI’s transition to an independent clinical-scientist who possesses the skills and expertise to use cutting-
edge mobile health methods to promote the implementation of evidence-based care for AYA oncology patients.
This proposal will inform the design of the PI’s large-scale multi-site hybrid effectiveness-implementation trial of
mPRISM (R01 proposal). Aligned with the NCI’s priorities, this program of research will promote evidence-
based behavioral interventions that improve quality of life, the utilization of portable low-cost technologies to
expand access to care, and implementation science initiatives to bridge the research-practice gap.

Public health relevance
PROJECT NARRATIVE Cancer among Adolescents and Young Adults (AYAs) is associated with poor psychosocial outcomes and quality of life, and patients experience disproportionately high levels of anxiety, depression, and posttraumatic stress in relation to their younger pediatric and older adult counterparts. Findings from the proposed project will help address the unmet psychosocial needs of AYA cancer patients using a novel mobile health psychosocial care delivery model with the advantages of appeal, reach, and cost-effectiveness. Ultimately, this work may help improve patient health-related quality of life and emotional well-being, and reduce the burden of cancer, by expanding access to evidence-based care.